Multi-Institutional Summer Undergraduate Research Program to Promote Diversity and Excellence in Sleep and Circadian Research Careers

ABSTRACT
The primary aim of this new multi-institutional summer research, educational, and professional development
training program is to prepare undergraduate students from underrepresented populations in the U.S. Biomedical
Sciences (UBR trainees) for advanced academic training in PhD and MD/PhD programs; foster their pursuit of
sleep and circadian science careers; and to promote a diverse workforce. The proposed training program is
unique as it provides UBR trainees mentoring by more than 30 faculty from NIH T32 programs in sleep and
circadian science, all of whom conduct research relevant to the mission of the NINDS. The program faculty and
advisory board also includes established URB investigators in this area nationally. Participating Institutions
include in alphabetical order: Harvard Medical School/Harvard University, Morehouse School of Medicine,
Northwestern University/Northwestern School of Medicine, Stanford University/Stanford University School of
Medicine, University of Colorado Boulder, University of Michigan, University of Pennsylvania/Perelman School
of Medicine, University of Texas Southwestern, and Washington University St. Louis. The program will recruit
60 UBR trainees and provide high quality research, core educational and professional development
experiences to prepare them for careers in sleep and circadian science. The multi-institutional effort will
provide access to training in all regions across the United States creating a community of expert mentors. The
training, research, and mentoring outcomes from this R25 program will foster diversity and inclusivity in the
scientific workforce and will contribute important scientific knowledge to our understanding of these critical
biological processes.

Public health relevance
Public Health Relevance Sleep and circadian rhythms are fundamental regulators of neurological function and their dysregulation cause, promote, and exacerbate neurological disorders. This educational program will increase the number of undergraduate students from underrepresented populations in the U.S. Biomedical Sciences for advanced academic training and foster their pursuing sleep and circadian science careers to promote a diverse workforce.